Understanding evasion of cell intrinsic innate immunity in viral populations with high rates of replicative failure

Cell intrinsic innate immunity is a barrier that all viral pathogens must overcome or otherwise subvert in
order to successfully complete their infectious lifecycle. Collectively, these pathways detect non-self or danger
associated molecules, and, in response, produce signaling proteins called interferons that induce both local
and systemic anti-pathogen responses. These responses ultimately drive the clearance of most acute
infections, although they also lead to much of the observed pathology. Most, if not all, viral pathogens encode
antagonists of these pathways; frequently at the level of interferon production. One such pathogen, human
influenza A virus, is so successful that only around 0.5% of infected cells successfully detect viral infection at
early timepoints. Nevertheless, that small fraction of responders is crucial to the course of
disease—individuals with defects in interferon pathways are often at extremely high risk of complications or
death following infection by respiratory viruses, including influenza.
Paradoxically, while most viral populations maintain stringent suppression of host detection, they
replicate with relatively low fidelity. For influenza, only about 10% of viral particles can successfully complete
the viral lifecycle. The rest of the particles are capable of entering cells and exposing potential innate immune
ligands, but nevertheless fail at some step to produce infectious progeny. Regardless, the vast majority of
virions, even those which cannot complete the viral lifecycle, still go undetected. What mechanisms, then,
allow viral populations to remain undetected by host cells despite failing so frequently at replication?
As a starting point to this ambitious line of inquiry, we are focusing on several discrete mechanisms in
influenza A virus for which we already possess either preliminary data or the capacity to readily procure such
data: 1) How the structure of the segmented genome of influenza A virus influences the range of potential
immunostimulatory failure 2) How the multifunctionality of influenza’s predominant innate immune antagonist,
NS1, influences rates of viral detection, and 3) How polymerase error rate may be subject to innate immune
pressure. To address these questions my group will use a combination of variant analysis, deep mutational
scanning, and more classical molecular virology. By profiling the challenges viral populations must overcome
to evade innate immunity, and the mechanisms by which they do so, it is our hope to better inform models of
viral evolution and potentially even identify novel therapeutic routes exploiting those challenges.
viral
Critically, our
approaches have already identified key components of the viral lifecycle that are subject to surveillance, and
have identified viral variants with desirable properties as potential vaccine candidates or oncolytic
therapeutics.

Public health relevance
Project Narrative A key component of success for most viruses is the antagonisim of the production of interferons, potent signaling proteins that drive the induction of an antiviral state. Critically, viruses must maintain this antagonism throughout all members of the the population, as detection of any single viral particle and subsequent interferon production endangers them all. This proposal seeks to understand how this difficult challenge is achieved by influenza A virus in the face of highly promiscuous replication machinery, in the hopes that such an understanding may provide insight into novel therapeutic targets as well as an improved understanding of viral evolution.